EFFECTS OF EXERCISE TRAINING ON RENAL PLASMA FLOW

The purpose of this study is to learn whether six weeks of exercise will change the blood flow to the kidneys and the overall kidney function and whether a heart medication known as digoxin (Lanoxicaps) will be eliminated from the body faster or slower as a result of exercise.